Biocatalytic Use of Cytochrome P450 Enzymes

DESCRIPTION (provided by applicant): The focus of this proposal is to expand the biocatalytic use of cytochrome P450 monooxygenase variants to include nitration and denitration of aromatic substrates, which to date has not been reported. Specifically, P450-BM3 (BM3) will be used in this study since it has been re-engineered to bind and transform a variety of abiotic substrates. The specific aims for this proposal are to: (1) Develop and evolve existing BM3 variants to utilize reactive nitrogen species to nitrate phenol, (2) Optimize the regioselectivity, product distribution, and substrate scope of BM3 mediated nitration, (3) Develop and evolve existing BM3 variants to function as a denitrase on 2-nitrophenol, and (4) Expand the substrate and reaction scope of denitration mediated by BM3 variants. Initially, existing BM3 libraries in the Arnold will be screened for nitration and denitration chemistries, and high throughput colorimetric screens have been designed to rapidly assay new enzyme activity. Additional mutant enzyme panels for the initial screening will be generated using site directed mutagenesis of key residues followed by directed evolution. Subsequent characterization of the resulting products and biochemical properties of the optimized variants will be used to prepare second-generation enzymes. Finally, the substrate scope for both nitration and denitration reactions will be expanded to small molecules (e.g. explosives, herbicides, fluorophores), pharmaceuticals, and biomolecules bearing the nitro functional group. If necessary, BM3 enzymes can be subjected to further rounds of directed evolution to optimize substrate binding and catalytic activity. Successful accomplishment of these aims will provide a fundamental insight into the use of P450 for new chemistries and will result in enzymatic tools that can be used for synthetic applications, environmental remediation, and diagnostics.

Public health relevance
PUBLIC HEALTH RELEVANCE: Nitroaromatics are chemical components of industrially produced pharmaceuticals, herbicides, and explosives and biological products of nitrative stress. The proposed research will design novel enzymes to mediate the formation and degradation of nitroaromatics under mild, aqueous conditions. This technology will have implications on public health research, as it will span functional use in the industrial production of small bioactive molecules and pharmaceuticals, environmental remediation, and diagnostics. __SpecificAimsTextDelimiter__ Specific Aims Biocatalytic Use of P450 to Nitrate and Denitrate Aromatic Substrates Cytochrome P450 enzymes (P450s) have been transplanted outside of their native biological milieu to canvas a large and customizable reaction space with transformations ranging from hydroxylation to halogenation.1,2 Mechanistically, molecular oxygen and hydrogen peroxide can bind the heme iron center buried in the P450 core and activate a catalytic cycle to oxidatively modify a number of biotic and abiotic substrates.1,2 Naturally occurring and engineered P450s have been characterized to form and cleave C-C, C-O, and C-N bonds, but in this context the C-NO2 bond has not been widely explored for native and engineered P450s.1-8 As such, heme monooxygenase based systems can be subjected to structure-guided mutagenesis and directed evolution techniques to transform the C-NO2 bond.2 It is important to note that the nitro (-NO2) functional group is incorporated into a wide range of biologically and industrially produced small molecules and pharmaceuticals.9,10 As such, the focus of this proposal is on the development of the well-studied variant cytochrome P450-BM3 (BM3) to mediate nitration and denitration reactions on aromatic substrates. This novel biocatalytic use of BM3 will be a versatile tool for a variety of synthetic applications, environmental remediation, and diagnostics. Specific Aim 1: Develop and evolve existing BM3 variants to utilize reactive nitrogen species to nitrate phenol. BM3 can utilize peroxynitrite (ONOO-) to self-nitrate at tyrosine and cysteine residues in the enzyme and nitrate phenol as a substrate.11 Initially, wild type and existing libraries of BM3 and BM3h variants will be screened for the selective nitration of phenol with peroxynitrite or molecular oxygen and nitric oxide (•NO) as sources for a nitration agent.12-15 The development of this enzyme is amenable to high throughput screening as the resulting nitro-product is yellow in color and can be detected at low micromolar levels.16 Structure-guided mutagenesis of key tyrosine and cysteine residues followed by directed evolution will be used to refine and improve nitration activity of BM3 and BM3h enzymes. Specific Aim 2: Optimize the regioselectivity, product distribution, and substrate scope of BM3 mediated nitration. Synthetic nitration of aromatic compounds requires harsh reaction conditions that can result in variable regioselectivity and product distribution.17 However, BM3 variants can be further engineered to overcome the limitations of classical organic nitration chemistry. Initial BM3 nitrating enzymes will be optimized to catalytically mediate a single nitration of small, substituted aromatic compounds with specific regioselectivity in mild solvent P450-BM3 mediated nitration conditions. Additionally, the substrate scope will be expanded to fused NO aromatic structures found in fluorophores and pharmaceuticals. -O2C O CO2- 2 NN Specific Aim 3: Develop and evolve existing BM3 variants to Fe4+ NN function as a denitrase on 2-nitrophenol. The biocatalytic use of S Enzyme BM3 enzymes will be expanded to oxidative or reductive denitration of OH OH aromatic substrates. Existing BM3 libraries will facilitate initial screening efforts for denitrase activity.12-14,18 Similar to other P450 NO 2 enzymes, BM3 could reductively denitrate to furnish 1,2- dihydroxybenezene and nitrous acid (HNO2).19-22 Alternatively, similar P450-BM3 mediated denitration to flavin-dependent monooxygenases, BM3 could denitrate and oxygenate 2-nitrophenol to produce 1,2-dihydroxybenzene and nitrite -O2C CO2- O (NO2-).10,23-26 Reaction of the product 1,2-dihydroxybenzene with ferric NN Fe4+ ammonium citrate will furnish a colorimetric readout of the enzyme N N activity that can be rapidly assayed.27 S O Enzyme OH O O2N Fe3+ Specific Aim 4: Expand the substrate and reaction scope of denitration mediated by BM3 variants. The resulting BM3 denitrase will be screened, subjected to structure-guided mutagenesis, and N [Fe(phen)3]2+ N evolved for its activity against a range of substrates and reaction (phen) conditions. Nitrated compounds that will be explored include substituted aromatic structures, fused aromatic structures, and Figure 1. New synthetic transformations mediated by P450-BM3 variants. heterocycles.